Dissecting the mechanism of altered immune responses during obesity

Obesity is a critical global epidemic, leading cause of preventable death, and source of skyrocketing health care
costs. According to the CDC, 42% of US adults are now obese, costing the US more than $173 billion/ year.
Alterations in immune populations such as macrophages and T cells accompany inflammation, metabolic
disease, and poor infection outcomes in obese patients, but there is growing appreciation for important B cell
contributions to inflammation and metabolic disease as well. The recent viral pandemic has highlighted the
negative immune consequences of obesity, with obese patients showing suboptimal vaccine responses,
increased disease pathology, and worse clinical outcomes than lean patients.
As part of our efforts to dissect the immune changes during obesity, we recently documented an increase
in an inflammatory B cell subset, Tbet+ CD11c+ B cells, in the spleen and adipose tissue of obese humans and
mice. These Tbet+ B cells are known to produce IgG2c, expand during infection, autoimmune disease, and
aging, and produce protective antibodies during acute infection. On the other hand, Tbet+ B cells with
autoimmune reactivity expand during chronic autoimmune diseases and aging. Our preliminary data suggests
that 1) obesity induces expansion of a class-switched, extrafollicular, likely low affinity, CD11c+ Tbet+ B cell
population in secondary lymphoid organs, 2) but vaccination during obesity does not expand higher affinity GC
dependent B cells typically observed during acute infection. Our most compelling data shows that 3) the poor
clinical outcomes exhibited by obese animals can be restored by removing Tbet+ B cells. We hypothesize that
extrafollicular expansion of Tbet+ B cells during obesity skews humoral immune responses towards lower affinity,
shorter lasting IgG, rendering the animal less capable of mounting protective responses against vaccines and
infectious virus.
Successful completion of this project will provide insight into Tbet+ B cells as a potential therapeutic
target for increasing vaccine-driven and protective humoral immune responses in obese patients and may be
applicable to immunologically related conditions such as aging and autoimmunity, expanding the therapeutic
effect to other clinically vulnerable populations.

Public health relevance
Project Narrative Obesity is fast becoming a critical global epidemic, a leading cause of preventable death, and a source of skyrocketing health care costs. This project will identify key mechanisms utilized by a specific subset of B cells to mediate inflammation and inhibit responses to vaccination or immune defense to pathogens during obesity. One important outcome of this project will be to identify new therapeutic targets which may be used to re-establish a healthy immune balance to counteract the symptoms of obesity.